Strengthening Cigar Warnings to Prevent Adolescent Use

ABSTRACT
Over 1.4 million youth currently smoke cigars and recent data from the National Youth Tobacco Survey (2019)
indicate that cigars are the second most commonly used tobacco product among youth. Cigar use exposes
youth to the addictive effects of nicotine during a critical developmental period and increases their risks for
multiple cancers and premature death. Of the three major types of cigars—large cigars, little cigars, and
cigarillos—little cigars and cigarillos (LCCs) are the most commonly used in the US, particularly among
younger people. LCC use also contributes to tobacco health disparities, as Black/African American youth use
cigars more frequently than other youth. In 2016, the Food and Drug Administration (FDA) mandated six
rotating text-only warning statements to be on LCC packaging. Little research has examined the effectiveness
of the FDA-mandated LCC warnings in reducing youth willingness to use LCCs. Research from studies of
cigarettes suggests that effective warnings should be large and include images that illustrate the negative
health effects associated with use. However, evidence for cigarette warnings cannot adequately inform
implementation of improved LCC warnings because: 1) there is no evidence on the effectiveness of the FDA-
mandated text-only LCC warnings on behavioral intentions or outcomes among youth; 2) courts have ruled that
effective tobacco warnings on one type of tobacco product (i.e., cigarettes) cannot be used to justify warnings
on other types of tobacco (i.e., LCCs), and 3) LCC users have different demographic and consumption profiles
than cigarette users. Furthermore, the US Court of Appeals for the DC Circuit recently ruled that the FDA
cannot require warning labels for cigars, claiming that the FDA did not provide evidence on the impact of cigar
warnings on smoking rates, including initiation and cessation.
Our goal is to conduct research that advances the science on LCC warnings that are effective for
youth ages 15 – 20 who currently use, have ever used, or are susceptible to using LCCs, especially
Black/African American youth. We will achieve three aims over the three-year grant. Aim 1 will identify the
most effective images to pair with FDA-mandated LCC text-only warning statements using a youth advisory
board and a quantitative online survey delivered to 500 youth. Aim 2 will experimentally examine whether LCC
warning size (30% vs 50%) and type (text-only vs. text + image) affect perceived message effectiveness of
LCC warnings among a separate online sample of 500 youth. In Aim 3, we will conduct a randomized
controlled trial with 900 youth to test whether the most effective LCC warnings from Aim 2 reduce willingness
to use LCCs against the text-only 30% size FDA-mandated LCC warnings and a control condition. Our Aim 3
trial will be delivered to youth through an online survey link embedded in text messages. Our study will
provide data and actionable evidence that FDA and policy makers need to implement strengthened
LCC warnings aimed to reduce LCC use among youth and decrease tobacco-related disparities.

Public health relevance
The research study seeks to improve the effectiveness of warnings for little cigars and cigarillos (LCCs) among youth who currently use, have ever used, or are susceptible to using LCCs, especially Black/African American youth. Scientific findings will provide novel and necessary evidence regarding the effectiveness of LCC warnings and will inform efforts to strengthen warnings through larger warning size and added images. Ultimately, this research can be used to reduce LCC use among youth and lessen tobacco-related disparities.